Theory and Modeling of Biomolecules and their Interactions - Equipment Supplement

Project Summary/Abstract
The establishment of tools from statistical mechanics and computer simulation that enable the exploration of
biological molecules and their interactions are central to discovery within biomedical research. This proposal
supports ongoing efforts in this area, addressing challenges in theory and modeling, as well as strategically
chosen collaborations on important biomedical questions that provide crucial tests of the approaches. Our
development efforts include the exploration of receptor-ligand interactions and the thermodynamics of ligand
binding to biological receptors through the development and application of novel methods of free energy
simulations, docking and receptor-ligand interaction modeling. The continued refinement, hardening and
application of methods of constant pH molecular dynamics to integrate the critical aspects of pH and protonation
state changes in biomolecules and their ligands in molecular simulations and modeling is also part of ongoing
work. Finally, software infrastructure, specifically the CHARMM simulation package, provides the framework for
advancing our methodological approaches and enabling the broader community to explore biomedically
motivated questions via its wide usage and distribution. We will continue the innovative implementation of
methods and simulation approaches into this community standard software package. We will balance and drive
our development efforts in the areas of free energy simulations, ligand – receptor docking and pH-mediated
structure-function processes through strategic collaborations with experimental colleagues in the areas of:
transcriptional activation based on small amphipathic molecules targeting co-activators from the CREB binding
protein (KIX) and the AciD domain of Med25; key cancer targets such as menin-MLL; enzyme redesign and
substrate scope expansion to better understand the evolution of function of a novel Flavin-dependent
hydroxylase for chemical transformations important in the development of pharmaceuticals; pH-regulated
sensors in kinase signaling associated with the G-protein from the tetrameric Gai protein; the pH-modulated
switch for myristoylated histactophilin, an actin binding protein homolog with interleukin-1b and fibroblast growth
factor. Finally, we will engage developers of big data applications of molecular simulations and the design and
execution of robust user APIs to work with us toward advancing software development for large multi-scale
simulations of cellular environments and automated workflows, through CHARMM-GUI, for simulation protocols.
This requested supplement provides a critical update to the computational infrastructure needed for the
developments and applications proposed as part of our R35 award. We have made significant efforts to map
computational algorithms onto accelerated computing platforms (GPUs) and the proposed instrumentation will
enable access to the latest of these platforms, replacing standard CPU and aging GPU platforms that are beyond
their useful lifespan, thus facilitating the productivity of algorithm development and key biomedical applications.

Public health relevance
Project Relevance The goal of this research effort is to develop novel and versatile methods to study, via computer simulation, biological molecules and their interactions with a specific focus on methods for small molecule (drug-like) interactions with their biological receptors and the pH-dependent mediation of biomedically important processes. Using a multidisciplinary approach, improvements in theory and methods will be tested through strategic biomedical applications with experimental collaborators, and new insights into fundamental biomedical questions relating transcription, cancer and signaling will be addressed.